Glutaminase in Arterial Injury and Disease

PROJECT SUMMARY
The broad long-term goal of this proposal is to establish the enzyme glutaminase-1 (GLS1) as a critical
mediator of lesion formation in arterial injury and disease. GLS1 is a mitochondrial enzyme that metabolizes
glutamine (Gln) to glutamate (Glu) and ammonia (NH3). GLS1 plays a critical role in neurotransmission, acid-
base balance, angiogenesis, hepatic fibrosis, and tumor growth, but little is known regarding the function of
GLS1 in vascular smooth muscle cells (SMCs). However, preliminary studies demonstrated that the
proliferation, migration, and survival of SMCs is highly dependent on the presence of Gln. It was also
discovered that SMCs exclusively express the GLS1 isoform, that overexpression of GLS1 stimulates SMC
migration, and that inhibition of GLS1 activity or expression blocks SMC DNA synthesis or migration,
respectively. Moreover, Glu, but not NH3, substitutes for Gln in promoting SMC proliferation and collagen
synthesis. Additional experiments revealed that growth factors and glucose stimulate GLS1 activity in vascular
SMCs. Final pilot experiments also demonstrated that arterial injury and diabetes induces the expression of
GLS1 in the vessel wall, and that inhibition of GLS1 activity or genetic depletion of GLS1 attenuates neointima
formation following arterial injury as well as arterial fibrosis and stiffening in diabetic animals. Based on these
findings, it is proposed that GLS1 plays an integral role in aberrant arterial remodeling by stimulating SMC
proliferation, migration, collagen synthesis, and survival by metabolizing Gln to Glu and NH3. This hypothesis
will be tested in three interrelated specific aims. In aim 1, the role of GLS1 in regulating SMC function will be
determined. These studies will investigate the effect of GLS1 gene delivery on SMC proliferation, migration,
collagen synthesis and survival, and determine the role of the various GLS1 products on these processes.
They will also explore if the induction of GLS1 by growth factors contributes to their ability to promote SMC
proliferation, migration, and collagen synthesis. In aim 2, the role of GLS1 in regulating the arterial response
to injury will be established. These studies will examine the time-course of GLS1 expression in injured rodent
carotid arteries, and determine if pharmacological inhibition of GLS1 activity, silencing GLS1 expression, or
genetic deletion of GLS1 in SMCs attenuates the remodeling response following arterial injury. In aim 3, the
role of GLS1 in aberrant arterial remodeling and hypertension in diabetes will be investigated. These studies
will examine the effect of glucose on GLS1 expression both in cultured vascular SMCs and in arteries from
diabetic mice. In addition, they will examine if GLS1 contributes to glucose-mediated alterations in SMC
function, arterial remodeling, and hypertension in diabetic mice. It is anticipated that these studies will
establish GLS1 as a key regulator of SMC proliferation, migration, collagen synthesis, and survival. They may
also also identify GLS1 and its products as novel contributors to lesion formation following arterial injury, and
establish GLS1 as a new translational target in treating abnormal remodeling and hypertension in diabetes.

Public health relevance
Project Narrative Cardiovascular disease and stroke claims more lives and costs more money than any other disease in the United States of America. Studies in our laboratory have identified the enzyme glutaminase-1, which metabolizes glutamine to glutamate and ammonia, as a critical regulator of vascular smooth muscle cell function. This project will investigate whether glutaminase-1 contributes to neointima formation following arterial injury, and if it mediates abnormal arterial remodeling, increased arterial stiffness, and hypertension in diabetes.